Chicago Kidney Urology Hematology network FOR city-Wide reseArch tRaining and career Development (Chicago KUH FORWARD)

NIDDK-funded training programs have been essential for fostering the career development of scientists and physician-scientists tackling questions in the kidney, urology and hematology (KUH) research areas, but these programs have yielded varying degrees of success. To best meet future challenges, NIDDK understands the need to train promising individuals for interdisciplinary team science and draw upon extensive, collaborative resources to establish communities of trainees. Chicagoland is a metro area rich in world-class medical centers and other resources essential to establish such an interdisciplinary training program and make sustained impacts on KUH research training. Our program brings together 6 public and private academic institutions that provide unique and complementary training opportunities across Chicagoland. These critical assets must be coordinated to yield the best training opportunities for fellows and to maximize effectiveness of the Professional Development, Network and Training Cores. The Administrative Core will ensure effective function of our program through establishing shared governance, collaborative workflow, continual assessment and improvement, and disseminating the work and successes of trainees through yearly Institutional Network meetings. The Specific Aims of the Administrative Core are: 1) Establish an organizational and governance structure fostering communication, collaboration and integration; 2) Develop comprehensive program evaluation, data review and cycles of improvement; 3) Establish an External Evaluation Board for performance oversight; and 4) Organize a meeting of the Institutional Network. The Administrative Core will be led by experienced directors with extensive backgrounds in overseeing training programs, shared leadership, and managing large collaborative research projects. They will be assisted by dedicated Program Manager, who will serve all aspects of the program and will facilitate effective communication and integration of Cores and Committees. Experts in education and evaluation will lend their expertise to ensure continual cycles of evaluation and improvement. An inter-institutional Steering Committee will oversee coordination across institutions and disciplines. Together, successful completion of the Aims and effective function of the Administrative Core will result in an interdisciplinary and collaborative environment that draws upon the unique and complementary strengths of our world-class research institutions to train the next generation of KUH researchers. This training environment will contribute to an important Institutional Network.

Public health relevance
Project Narrative Overall The research workforce in areas of Kidney, Urology and Hematology (KUH) needs to be strengthened in order to address pressing scientific questions and find treatments for patients affected by KUH conditions. The current proposal will create an innovative training program that will bring together pre- and postdoctoral trainees across 6 academic institutions across Chicago who will learn together about cross-cutting tools in a way that will allow them to develop a common language, apply the tools into their own research, and form sustained interdisciplinary research interests and collaborations. The results will have important implications for the KUH scientific community and for clinical care of patients with KUH conditions.